Malawian Program for Mental Health Research Training (WARMHEART)

SUMMARY
Globally, mental health disorders account for nearly a third of years lived with disability and are the fifth-
leading cause of disability-adjusted life years. Approximately three-quarters of this burden resides in low and
middle-income countries, where a particularly large “mental health treatment gap” exists. This gap is particularly
striking in sub-Saharan Africa (sSA), where extremely limited mental health treatment capacity exists; less than
1 in 27 of those with a mental disorder get minimally adequate treatment.
The development of in-country leaders in mental health research and policy translation is critical to address
this mental health treatment gap in sSA. The Malawian Program for Mental Health Research Training
(WARMHEART) program has begun to address the treatment gap in Malawi and aims to accelerate mental
health research capacity and policy development in the next five years.
In Malawi, known as “the warm heart of Africa,” the country’s first psychiatrist in a generation completed
medical training seven years ago. Kamuzu University of Health Sciences enthusiastically supports expansion of
its mental health faculty and research. Multiple funded mental health research grants provide a rich opportunity
for mentored research experiences, and the Ministry of Health mental health unit is committed to translating
research to practice.
Building on our first cycle’s success, this renewal transitions leadership from the University of North
Carolina-Chapel Hill (UNC-CH) to Kamuzu University of Health Sciences (KUHeS) and employs a model to
accelerate mental health research capacity across the lifespan in Malawi by emphasizing three complementary
dimensions: depth, breadth, and reach. This initiative builds on the strong training track records of and
successful collaborations between KUHeS, UNC-CH, the Malawi Ministry of Health, and many other partners.
Specifically, we will 1) train 5 clinical psychiatry researchers and 4 postdoctoral mental health research
fellows who will participate in leadership training; Individualized tailored training packages’ special courses on
implementation science, newer research methods, qualitative research, and policy translation, mentored
research projects, writing workshops, and conference attendance (depth); 2) hold broad initial stakeholder
meetings to prioritize research and policy questions, require cross-specialty collaboration in mentored research
projects, enhance mentorship skills among in-country faculty, and sponsor regular mental health journal clubs
and mental health conferences for a broad audience (breadth); and 3) extend the impact of these researchers
through leadership and policy translation training, require collaboration with a policymaker in mentored research
projects, and hold a policy translation meeting at the end of the project period (reach).
WARMHEART will expand the expert pool of mental health researchers trained as leaders and able to
collaborate with other disciplines and policymakers to address the role of psychiatric illness across the lifespan.

Public health relevance
NARRATIVE Building on the strong training track record of the first funding cycle, the Malawian Program for Mental Health Research Training (WARMHEART) will strengthen the collaboration between Kamuzu University of Health Sciences and UNC-Chapel Hill, and accelerate mental health research capacity across the lifespan in Malawi by employing a model that emphasizes three complementary dimensions: depth (in-depth investment to create a core of skilled researchers and thought leaders), breadth (engagement of a wide range of stakeholders in mental health research), and reach (building links between research, policy, and practice to maximize impact of research). Leadership will transition from UNC-Chapel Hill to Kamuzu University of Health Sciences. WARMHEART will continue to have a tremendous impact on mental health research in Malawi, expanding the expert pool of young mental health researchers trained as leaders and able to collaborate with other disciplines and policymakers to address the role of psychiatric illness across the lifespan.